Human Translational Bioinformatics Core

PROJECT SUMMARY
The overall objective of this SCORE is to elucidate sex differences in cardiometabolic disease and its risk
factors and treatments using genetically modified mouse models, inbred mouse strains, and in vitro or cell-based
experiments. However, another important component of the SCORE is to translate findings from model systems
to humans. The Human Translational Bioinformatics Core will fulfill this goal by serving as the hub for
computational and in silico analyses that translate findings from the three Projects for association and relevance
to cardiometabolic traits in humans, thereby enhancing the overall research results of the SCORE. The Core
will be led by Dr. Hooman Allayee, whose own research program has developed numerous bioinformatics and
analytical pipelines to efficiently and systematically evaluate the role of candidate gene/molecular/biomarker
targets in cardiometabolic diseases using large human datasets. Furthermore, the computational infrastructure
is in place and access to a wide array of 'omics data is already available from numerous multi-ancestry cohorts.
Taken together, these tools have been successfully applied in prior studies and will serve as the paradigm for
how the Core will support the three SCORE Projects. Specific Aim 1 will use these resources to investigate
sexually dimorphic candidate gene/pathway, transcriptomic, proteomic, and metabolomic biomarkers identified
by the three Projects for relevance to human populations. These analyses will leverage primary-level data (i.e.
genotypes, clinical outcomes, and biomarker levels) from several population- and hospital-based cohorts with a
combined sample size of >500K subjects. As such, epidemiological, genetic, and causal association analyses
can be carried out with increased granularity. Specific Aim 2 will complement this approach by leveraging
publicly available summary-level data for various `omics data from large-scale genome-wide association studies
(GWAS). This strategy will provide even greater power and expand the bioinformatics analyses to additional
clinical, proteomic, and metabolomic traits due to the large number of subjects and diverse outcomes in the
studies from which the data are drawn. Finally, Specific Aim 3 will create a web-based resource that houses the
internally driven and publicly available data from the first two Aims, which will be made available to the three
SCORE Projects and, in a controlled manner, to the broader research community. The resource will be
developed with PheWeb, an easily implementable and widely used open-source tool for visualizing, navigating,
and sharing GWAS and phenome-wide association study (PheWAS) results. The goal will be to provide an
intuitive and searchable interface for exploring genetic associations of candidate genes/variants with `omics traits
in humans. The culmination of Core activities may, in turn, reveal additional biological information and lead to
new hypotheses that can then be investigated mechanistically by the same basic science approaches being
used by the three Projects. The collective experience of its leadership/personnel in carrying out the proposed
bioinformatics analyses ensures an important contribution from the Core to the overall success of this SCORE.

Public health relevance
PROJECT NARRATIVE The overall objective of Center is to use a series of basic science experiments to understand how risk for cardiometabolic diseases differs between men and women. The role of the Human Translational Bioinformatics Core will be to serve as the hub for computational analyses that translate findings from the experimental projects for association and relevance to cardiometabolic traits in humans. These cost-effective and efficient analyses may, in turn, reveal additional biological information and lead to new hypotheses that can be investigated experimentally.